Building methods to assess and address cardiovascular health in transgender adults

Project Summary:
Guided by current prediction models utilized to address and prevent atherosclerotic cardiovascular disease
(CVD), the proposed project investigates how gender identity and hormone therapy are related to
cardiovascular health in transgender adults. The projects three specific aims are to: 1) evaluate a robust
method of identifying transgender individuals within claims data and compare this method to the gold-standard
of self-identification with data from Fenway Health, a federally qualified health center and leader in transgender
health; 2) assess current prediction models for CVD (i.e., Pooled Cohort Risk Assessment Equation) utilizing
C statistics, net reclassification, and integrated discrimination index for transgender individuals by accounting
for sex assigned at birth, gender identity, and use of exogenous hormones.; and 3) examine the knowledge
and attitudes of 160 transgender adult regarding potential risks associated with hormone therapy and
perceived barriers, facilitators, and acceptability of interventions affecting cardiovascular health. Completing
the proposed aims will 1) improve the accuracy of research with administrative data; 2) enhance clinical
decision-making for transgender adults seeking hormone therapy; and 3) inform risk mitigation strategies to
improve cardiovascular health of transgender adults. By engaging in mentored research with Drs. Emelia
Benjamin (Mentor), Michael Paasche-Orlow (Mentor), Howard Cabral (Mentor), and Sari Reisner (Mentor), and
collaborators, completing coursework, and participating in seminars, conferences, and regular mentoring
meetings, I will develop expertise in four new areas critical to my development as an independent clinician-
scientist evaluating health outcomes to characterize and mitigate CVD risks for transgender individuals: 1)
Quantitative methods to analyze claims-based & electronic health record data; 2) Quantitative methods to
assess prediction models; 3) Clinical skills in transgender endocrinology, cardiology, & preventive care; and 4)
Qualitative research & community engagement skills. Moreover, I will extend my grant writing and oral
presentation skills by participating in grant writing courses and presenting at research meetings and
seminars. Boston University offers junior scholars with the intellectual and practical resources they need to
develop into successful independent investigators, including junior faculty seminars, grant writing, editing, and
review services, and opportunities for intellectual exchange and collaboration with senior colleagues. A K01
award will provide me with the research experience, skills, and mentorship I need to build a cutting-edge
independent research program that assesses and addresses cardiovascular health in sexual and gender
minorities, particularly transgender adults.

Public health relevance
Project Narrative: Doctors use prediction models to help them prevent heart attacks and stroke in healthy adults. However, these models do not apply to everyone, including transgender and cisgender adults using hormone therapy. This project aims to provide new methods of predicting and preventing heart attacks and strokes in these unique groups of people.